Clinical Pharmacology of Efavirenz Combined with High Dose Rifapentine

Project Summary
Dr. Anthony Podany is applying for a patient oriented career development award (NIH-K23) for training in
clinical trial design and implementation and training the in techniques of pharmacokinetic modeling and
pharmacometrics. As part of the award, he plans to complete a Masters degree in pharmacometrics at the
University of Maryland. This training builds upon Dr. Podany’s previous training in infectious disease
pharmacology.
The members of Dr. Podany’s mentoring team are Drs. Courtney V. Fletcher, Richard E. Chaisson, Susan
Swindells, and Kim Scarsi, all internationally recognized leaders in HIV and tuberculosis research. Dr.
Courtney V. Fletcher will serve as Dr. Podany’s primary mentor and will facilitate continued training in HIV and
TB pharmacology, and in responsible conduct of research. Dr. Podany will also complete other didactic
training in responsible conduct of research in the classroom through the Collaborative Institutional Training
Initiative (CITI) and Clinical Research Symposium for junior faculty at the University of Nebraska Medical
Center.
Training in pharmacokinetic modeling will be achieved though didactic coursework from the University of
Maryland, with practical training under Dr. Richard Brundage, who is an expert in pharmacokinetic modeling.
His instruction will be an essential component of Dr. Podany’s training.
Data from Dr. Podany’s research will help bring about novel therapeutic options for the treatment of latent and
active tuberculosis disease in patients who are also infected with HIV. Data from this research will inform the
field and guide updates for guidelines on the treatment of HIV/TB co-infected patients. The project is of high
human health relevance.
On completion of the award period, Dr. Podany will have the expertise to conduct independent research in HIV
and tuberculosis pharmacology. He will have completed in-depth training in pharmacokinetic modeling and
clinical and translational research, allowing him to become a leader in the field of HIV and tuberculosis
pharmacology.

Public health relevance
Project Narrative The goal of this application is the career development of the candidate, Dr. Podany, to become an independent investigator in the field of HIV and tuberculosis pharmacology. The candidate’s research project is key to deciphering drug interactions when treating HIV and tuberculosis concomitantly. Data from these experiments will guide future updates to treatment guidelines for persons infected with both HIV and tuberculosis. Dr. Podany will develop skills in patient-oriented, clinical and translational research, and in pharmacokinetic modeling to become a successful independent investigator.